Comprehensive Liquid Biopsy for Early Stage I/II Screening and Diagnostics of Lung Cancer

ABSTRACT Circulating cell-free DNA in the bloodstream holds the promise of non-invasive “liquid biopsies” for cancer diagnostics. Mutations that drive the growth and spread of tumors are present and detectable within this genetic pool despite being outnumbered by vast amounts of wild-type DNA. However, there are no single genetic biomarkers of cancer and so to be of practical use many possible mutations must be screened simultaneously. Current techniques lose the high sensitivity required for this needle-in-a-haystack search once multiple mutations are targeted. Lariat Biosciences is developing new technologies that break this trade-off between sensitivity and breadth, providing for the first time the complete tools necessary to mine the bloodstream for clinically actionable signs of cancer. The Lariat technology pairs the exquisite sensitivity of emulsion digital PCR, capable of mutant quantitation at mutant-to-wild-type ratios of 1:105 to 1:106, with the ability to isolate and deeply characterize the detected mutant DNA afterwards. With orthogonal methods of DNA identification, the false positives that undermine the multiplexed sensitivity of current techniques are eliminated. Lariat’s initial product offering will be a comprehensive genetic screen for the common actionable mutations in pre-treatment non-small cell lung cancer that will be useful for screening at-risk populations and for predicting initial patient response to tyrosine kinase inhibitor drugs.

Public health relevance
NARRATIVE Circulating cell-free DNA in the bloodstream holds the promise of noninvasive “liquid biopsies” for cancer diagnostics. Mutations that drive the growth and spread of tumors are present and detectable within this genetic pool despite being outnumbered by vast amounts of healthy wild- type DNA. Lariat Biosciences is developing new technologies that provide for the first time the complete tools necessary to mine the bloodstream for clinically actionable signs of cancer.